Examine the function of APOBEC3B in epithelial ovarian cancer stem cells

SUMMARY/ABSTRACT
Ovarian cancer is the most lethal gynecologic malignancy and is frequently diagnosed at an advanced-stage.
One of the most aggressive types of ovarian cancer is epithelial ovarian cancer (EOC) and 5-year survival is less
than 20%. In recent years, PARP inhibitors (PARPi) has shown impressive therapeutic efficacy as both
maintenance therapy and in recurrent setting. However, since the wide application of PARPi, patients ultimately
develop drug resistance to PARPi which leaves them with few treatment options. Thus, the development of novel
therapies to overcome PAPRi resistance represents an urgent unmet medical need. The PARPi-resistant
patients often have enriched cancer stem cells (CSCs) with enhanced pro-survival and self-renewal capacity.
Evidence demonstrations that EOC CSCs are responsible for primary tumor growth, metastasis, disease relapse
and resistance to chemotherapy, suggesting CSC is an attractive target for eradicating EOC. Our long-term goal
is to identify new targets for development of less toxic and more effective therapies by eliminating this cell
population. Apolipoprotein B mRNA editing enzyme catalytic polypeptide-like 3 (APOBEC3) proteins are a family
of DNA deaminase that catalyze cytidine to uridine (C-to-U) on single-strand DNA. This important DNA
modification is abundant in a wide array of cancer types and represent the only enzymatic source of mutations.
We discovered that APOBEC3B (A3B) is the main DNA mutators in EOC CSC. The C-to-U DNA mutation activity
and A3B expression is reduced in EOC CSCs compared to non-CSCs. Importantly, inhibition of A3B leads to
PARPi resistance, elevated frequency of CSCs, and enhanced expression of stemness factor SOX2. These
novel insights raise the possibility that A3B activation may sensitize EOC CSCs to PARPi. Our central hypothesis
is that EOC CSCs maintain low level of A3B in order to avoid excess DNA damage thereby counters the effect
of PARPi. The overall goal of this study is to dissect the mechanism through which A3B and DNA deamination
regulates CSC maintenance and promote response to PARPi in EOC CSC. We will address our hypothesis in
two specific aims: 1) Determine if modified A3B activity will sensitize CSCs to combination therapy with PARPi,
2) Identify the novel mechanisms by which A3B regulates response to PARP inhibitor in EOC CSCs. We will
perform A3B overexpression studies in patient-derived organoid models and comprehensively evaluate changes
in EOC CSC functions and the response to PARPi. Mechanistically, we will assess DNA damage pathways,
chromosomal abnormalities, and ssDNA break levels in CSCs that overexpress A3B alone and in combination
treatment with PARPi. In addition, the molecular mechanism of how A3B regulates CSC’s response to PARPi
will also be examined. This innovative study will improve our understanding of how A3B sensitize EOC CSCs to
PARPi by promoting DNA damage and uncover valuable novel therapeutic targets to preventing ovarian cancer
relapse. These mechanisms may be broadly applicable to other CSC-driven malignancies.

Public health relevance
NARRATIVE The proposed work is relevant to NIH’s mission statement because it seeks to dissect the precise mechanisms by which DNA editing enzyme APOBEC3B regulates response to PARP inhibitors in ovarian cancer stem cell. Thus, it will fundamentally advance our mechanistic understanding of the molecular mechanisms contributing to cancer stem cell-driven drug resistance.